Decoding Neuroimmune Interactions to Enhance Craniofacial Bone Healing

Cranial bone is richly innervated with sensory nerves that play critical roles in fracture healing by signaling and
regulating osteoprogenitor function. This is supported by our prior findings which suggest that small-molecule
mediated (i.e. TrkA (tyrosine kinase A) agonists) stimulation of nerve sprouting into calvarial defects enhances
bone formation while TrkA inhibition using a chemical-genetic approach abrogates bone repair. In contrast to
normal fracture healing, critical-sized, craniofacial bone defects require therapeutic intervention such as the
delivery of biomaterials and stem cells. In preliminary studies, we have observed that the delivery of exogenous
stem/stromal cells to cranial bone injuries magnifies neural ingrowth associated with bone healing, suggesting
that stem cells may regulate bone repair in part by impacting these early-stage neural interactions. To optimize
the efficacy of these bioengineering strategies, we will define the neuro-immuno-skeletal signaling axis during
bone repair across healing and non-healing cranial bone injuries and elucidate how biomaterial- and stem cell-
delivery impacts this signaling axis. We will employ a quantitative light-sheet microscopy (QLSM) platform to
visualize and quantitatively describe β3-tubulin labeled nerve responses to 1-mm and 4-mm full-thickness
injuries in the parietal bones of mice. We will combine this information with corresponding single cell RNA
sequencing (scRNA-seq) data obtained from cells at the injury sites and the nerve bodies in the trigeminal
ganglia which provides sensory innervation to the skull. We propose three Specific Aims: In Aim 1 We will create
1-mm or 4-mm injuries in the parietal bones of 12-week old Baf53b-tdTom mice, in which all peripheral nerves
express a tdTomato reporter. We will image macrophages, axons, and osteoprogenitors at multiple time points
following injury. Additionally, we will perform timelapse scRNA-seq on cells isolated from both the injury site and
trigeminal ganglia and interrogate the reciprocal signaling interactome between early responding macrophages
and recruited peripheral nerves in injuries and decipher how these impact osteoprogenitor recruitment and
differentiation into osteoblasts. In Aim 2, we will Independently manipulate the magnitude and duration of TrkA+
nerve sprouting using agonists and inhibitors and evaluate the impacts on signaling and cranial bone healing.
With either gain or loss of function approaches, changes to the neuro-immuno-skeletal signaling landscape and
bone repair outcomes will be assessed using spatial and sequencing methods as described in Aim 1. Lastly, in
Aim 3, we will design, fabricate, and test bi-functional scaffolds which provide spatially and temporally controlled
release of neurotrophic factors and neural inhibitors to orchestrate the appropriate signaling cascade that
maximizes bone healing in critical-sized calvarial injuries in mice. Overall, we will combine information on ligand-
receptor signaling into an engineering strategy to maximize the therapeutic outcomes via the neuro-immuno-
skeletal signaling that promotes therapeutic cranial bone healing.

Public health relevance
In this study, we will elucidate the neuro-immuno-skeletal signaling interactions that influence cranial bone healing. Using advanced imaging and transcriptomic approaches, we assess how the kinetics of neural ingrowth following cranial bone injury impacts intercellular crosstalk and bone healing. Finally, we will exploit this improved insight to enhance biomaterial-mediated therapies to repair bone injuries.